Nr4a1 and the expansion of functional beta-cell mass

PROJECT SUMMARY/ABSTRACT
Loss of functional beta cell mass is a hallmark of Type 1 and Type 2 diabetes. Increasing beta
cell mass could be used as a treatment for diabetes. GLP1-R mediated signaling and inhibition
of Dyrk1a activity are sufficient to increase functional beta cell mass. Nr4a1 is essential for beta
cell proliferation and insulin secretion. Recent findings from our laboratory demonstrate that
GLP1-R signaling results in upregulation of Nr4a1 in the beta cell. Similarly, Dyrk1a inhibition by
Harmine, and Harmine derived compounds, results in upregulation of the Nfat family of
transcription factors. We have shown that Nfatc2 and Nfac3 induce Nr4a1 expression, and that
Nr4a1 deletion impairs Nfatc2 mediated beta cell proliferation. While these data suggest that
Nr4a1 is essential for both the GLP-1R and Dyrk1a regulated beta cell proliferation pathways,
and suggest an alternative target to expand functional beta cell mass, there are fundamental
gaps in our understanding regarding Nr4a1 in these pathways, in terms of 1) the necessity of
Nr4a1 in Exendin 4 and/or Harmine mediated beta cell proliferation, insulin secretion, and cell
survival, 2) the effects of Exendin 4 and/or Harmine on Nr4a1 gene regulation in terms of
binding partner interactions, genomic localization, and 3) how enhancing Nr4a1 expression and
activity affects Exendin 4 and/or Harmine mediated beta cell proliferation. These gaps hinder
the rationale design of targeted therapies to improve functional beta cell mass as a treatment for
individuals with Type 1 and Type 2 diabetes. The long-term goal of our research is to develop
strategies to improve beta cell function, proliferation and survival to improve patient outcomes.
The overall objective of this proposal is to determine the role of Nr4a1 in the GLP1-R and
Dyrk1a mediated pathways that expand functional beta cell mass. Our central hypothesis is
that Nr4a1 is a key downstream that permits modulation of the GLP1-R and Dyrk1a pathways to
enhance functional beta cell mass. Guided by our preliminary data, this hypothesis will be
tested in the following specific aims: Aim 1: Determine the effect of Nr4a1 in GLP-1R and
Dyrk1a mediated functional b-cell mass expansion. Aim 2: Determine the effect of Nr4a1 in the
GLP-1R and Dyrk1a signaling pathway that leads to functional b-cell mass expansion. Aim 3:
Determine the effect of Nr4a1 pharmacological modulation on GLP-1R and Dyrk1a mediated b-
cell mass expansion. The proposal is innovative because it elucidates novel functions of Nr4a1
in these two proliferative pathways. The proposed research is significant because it fills
fundamental gaps in our understanding of an understudied beta cell regulator, Nr4a1, its role in
these critical pathways, and how its modulation can enhance functional beta cell mass.

Public health relevance
PROJECT NARRATIVE GLP-1R activation and Dyrk1a inhibition through Exendin-4 and Harmine treatment, respectively, are sufficient to enhance functional beta cell mass. The research proposed here is relevant to public health because an understanding of Nr4a1’s role in these pathways will increase our ability to rationally enhance beta cell function to improve the outcome for diabetic patients. This work is pertinent to the NIDDKs goal of elucidating the basic mechanisms of beta cell function to “disseminate science-based information on diabetes… to improve people’s health and quality of life.”